Biological Mechanisms of the Infarct Borderzone

ABSTRACT
Ischemic heart disease, the most common cause of death in the world, is a spatially heterogeneous injury.
Between areas of cell death and distant normal cells lies the borderzone (BZ), a complex and dynamic region of
cells that plays a critical role in infarct expansion and pathologic remodeling. Historically, it was challenging to
study the BZ because of reliance on bulk measurement techniques that combine it with infarct and remote zones
in uncontrolled proportions. However, our recently published work shows that the BZ can be redefined based on
gene expression using single cell/nuclei, spatial transcriptomics, and multiplexed FISH. This led to the Loss of
Neighbor Hypothesis, which proposes that the biology of the BZ is mechanically induced as a result of
destabilizing forces resulting from large areas of ischemic cell death. We propose that this secondary mechanical
injury is central to infarct expansion and precipitates nuclear envelope rupture and repair, which underlies infarct
expansion, pathologic remodeling, and development of heart failure. Aim 1 will investigate the relationship
between nuclear rupture, DNA damage, and cell fate at the infarct BZ. Aim 2 will delineate cell-type-specific roles
in initiation and propagation of the BZ during infarct expansion. Aim 3 will develop a therapeutic strategy to
modulate borderzone biology and limit infarct expansion. Success in this project will advance our understanding
of multiscale mechanisms in the BZ and reveal new opportunities for therapy to break the links between
myocardial infarction and development of chronic progressive heart failure.

Public health relevance
Ischemic heart disease is the most common cause of death in the US and the world. This proposal aims to investigate biological mechanisms in the borderzone after a heart attack with a specific focus on nuclear envelope rupture and its consequences. Finally, we will explore ways to therapeutically target this process to prevent progression to heart failure.